Student and Postdoctoral Travel Awards for the 2006 Meeting

[unreadable] DESCRIPTION (provided by applicant): The Teratology Society's Annual Meeting provides a forum for students and postdoctoral fellows to present their research and interact with some of the leading scientists in their field. The Society places a high priority on education and training and efforts to foster training are part of the investigators' strategic goals. The Annual Meeting is a major port of these efforts. This setting encourages an open exchange of ideas and experimental finding. The 2006 Annual Meeting will be held in Tucson, Arizona from June 24-29, 2006. The meeting program consists of symposium talks on current topics within the field, and poster and platform sessions for student and postdoctoral fellow submitted presentations, designed to inform attendees about the latest advances in birth defects research. [unreadable] [unreadable] The students and postdoctoral fellows are the future of both the Teratology Society and the science endeavors fostered by our community of scientists. Travel awards assist these students and postdoctoral fellows offset the financial burden of attending the Teratology Society Annual Meeting. Without this assistance many would not be able to take advantage of the rich exchange of scientific information and new ideas generated at this scientific meeting. In this proposal, the investigators are requesting funds to defray part of the cost of travel awards, which will be granted to students and postdoctoral fellows presenting their research finding at the 2006 Teratology Society Annual Meeting [unreadable] [unreadable] [unreadable] [unreadable]